Impact of a mobile phone crisis text messaging application on the spatiotemporal distribution of mental health outcomes among Utah adolescents.

Project Summary/Abstract
Suicide is a leading cause of death for individuals 10-24. Crisis counseling is a widely utilized intervention
that can, in principle, reduce the incidence of suicide. Text-message-based crisis counseling, which can be
delivered by smart phone, may be more accessible to teens and young adults than conventional, telephone-
based systems. In recognition of this, a consortium of stakeholders in Utah promoted the development of the
SafeUT crisis text-messaging app, which has been available to teens and young adults throughout the state
since 2017. At present, SafeUT handles over 2300 crisis encounters, or “chats”, per month. We hypothesize that
SafeUT has had measurable effects on critical mental health outcomes, such as emergency room visits for
suicidal behavior, hospitalizations for suicidal behavior, and suicide death, for youth throughout the state. To
evaluate this hypothesis, we will utilize geographically-informed statistical methods to measure the distribution
of these outcomes across Utah and how they change over time in association with SafeUT use. To facilitate
causal inferences, we will compare differences in outcomes before and after SafeUT implementation in Utah to
differences in these outcomes in Colorado over the same period. We also have access to several additional key
data sources—all unique to Utah—that represent mental health outcomes for youth within the state. First,
through the Utah Population Database, we have access to the Utah Department of Health Healthcare Facility
Database and the All Payer Claims Database: the former allows us to obtain information about youth
hospitalizations and emergency room visits for all causes including mental health crises while the latter affords
us access to information related to youths’ utilization of outpatient mental health and primary care appointments.
Data for hospitalizations, emergency room visits, and outpatient visits are available to us for Colorado through
the Colorado All Payer Claims Database. Additionally, we have an established relationship with the Utah state
Office of the Medical Examiner which has curated a database of geolocated suicide deaths. Using these unique
and powerful resources, we will first (Aim 1) evaluate demographic factors associated with SafeUT utilization in
census blocks and (at a different level of analysis) school districts throughout the state. Simultaneously, we will
(Aim 2) assess the effect of SafeUT implementation on emergency room visits, hospitalizations, and outpatient
mental health visits for youth (ages 10-24) in Utah compared to Colorado. Finally, we will (Aim 3) assess the
effect of SafeUT implementation on suicide death in Utah compared to Colorado. Ultimately, findings from our
studies will facilitate alterations in SafeUT to improve service delivery and inform suicide prevention efforts
throughout the country.

Public health relevance
Project Narrative Text-message-based services have the potential to greatly improve access to crisis support for persons who are at risk of suicide, especially for adolescents and young adults, who may be more comfortable using text- based platforms than voice-based telephone services. Utah has made a statewide text-message-based crisis service (SafeUT) available to teens and young adults since 2017. We propose to use advanced statistical analysis methods to assess, in a geographically-sensitive manner, the causal impact of SafeUT on key markers of adolescent crisis outcomes throughout the state, including emergency room visits, hospitalizations for psychiatric reasons, and suicide deaths, using comparison data from Colorado.